PROFESSIONAL DEVELOPMENT TOOLS TO IMPROVE THE QUALITY OF INFANT AND TODDLER CARE

This contract will support the development of professional development tools to improve the quality of infant and toddler nonparental care, building on the Quality of Caregiver-Child Interactions for Infants and Toddlers (Q-CCIIT) observation tool (2010-2014). This project supports ACF's vision for helping ECE programs and staff deliver quality services that promote positive outcomes for young children. The Q-CCIIT PD Tools project will: (1) create research-based Professional Development (PD) resources and materials that align with the Q-CCIIT; (2) design and conduct a field test to examine use of the PD tools in conjunction with the Q-CCIIT; (3) design a large-scale implementation and evaluation study of the measure and PD tools.